P30 Center Core Grant for Vision Research

ABSTRACT
Overall
The goals of this P30 Vision Core Renewal Application are to manage and maintain existing and new core
facilities that will provide expertise, technical support, equipment access, and personnel training for 24
independent vision research laboratories at the University of Oklahoma Health Sciences Center. We have had
two highly utilized and successful cores: Live Animal Imaging and Functional Analysis Core (AAC) (which has
been merged with the previous Genotyping Core), and a Cellular Imaging and Morphometric Analysis Core
(CIC). In this competing renewal, we have added a new Ocular Immunobiology Core (OIC) to provide new
equipment, training, and expertise for our rapidly growing interests in the immunological underpinnings of
ocular diseases. The AAC (two independent modules) is conveniently located inside of the two major vivaria
that house most of the vision research animals on campus, while the CIC and OIC are located in the
Department of Ophthalmology. Each core is directed by an NEI-funded investigator and supervised by highly
qualified and well-trained Systems Managers, Analysts, and Specialists who assist and train vision researchers
in the use of state-of-the-art resources. The availability of multiple types of advanced equipment, sophisticated
software, and hands-on training has dramatically increased the quality and quantity of research achievements
by the users of our Vision Core facilities. The P30 Vision Cores have: 1) increased opportunities for rigorous
translational research using clinically relevant and non-invasive imaging modalities, 2) generated collaborative
projects that require multiple areas of expertise, 3) increased and enhanced productivity of existing research
projects, thereby allowing participating investigators to remain competitive for funding, 4) promoted recruitment
of new faculty from other campuses, and 5) supported the development of new research strategies based on
the acquisition of data from the use of equipment otherwise unavailable to the PIs. Moving forward, the three
P30 Vision Cores will continue to provide a high level of expertise, instrumentation, and service, further
elevating our contributions to the forefront of vision science research.

Public health relevance
NARRATIVE Overall The P30 Vision Cores provide state-of-the-art facilities for clinically relevant research of the causes and treatments of blinding eye diseases. Our proposal fulfills the mission of NEl P30 funding because it will support the research of 16 health-related NEI-funded R01 grants held by 13 talented and productive investigators. The core modules will increase the productivity of current investigators, facilitate recruitment of new investigators, and stimulate the development of collaborative translational research projects.